Establishing and benchmarking advanced methods to comprehensively characterize somatic genome variation in single human cells

Abstract
Understanding somatic genomic variation presents unique challenges, primarily stemming from
the individual rarity of most somatic mutations across cells in a multicellular organism. Hence,
both sensitivity and accuracy (due to the need to distinguish somatic variation from noise) become
crucially important. The Analysis of bulk DNA, even with ultraprecise approaches, only ascertains
a portion of the human genome. The analysis of single cells, either by cloning or in vitro whole-
genome amplification (WGA), enables discovering theoretically all mutations in a cell independent
of their frequency in bulk. However, amplifying single cell genomes in vitro represents still a
significant challenge in terms of accuracy of amplification. The novel PTA technique (primary
template directed amplification) offers substantially improved quality of amplified DNA. However,
PTA produces a relatively small amount of DNA fragments of moderate length. This limits the
application of long read sequencing. Long read sequencing is expected to be the most
comprehensive approach to somatic mutation detection. In the parent award project, we will, first,
produce clonally expanded iPSC lines from several different tissues of a live donor, to study
somatic mutation of all types using non-enzymatically amplified genomic DNA. Second, we will
address a significant shortcoming of the analysis of single cell genomes, which is the lack of direct
information about the exact type of cell being analyzed, or about potential functional
consequences of mutations in that cell. For that, we will benchmark the new ResolveOme method,
that can analyze in parallel the genome and transcriptome of a single cell. Third, we will address
the challenge of high-throughput analysis of single cells to detect somatic structural variants.
Specifically, we will establish and benchmark for SMaHT the Strand-seq method that allows for
high-throughput detection and characterization of structural variants (SVs) in single cells.
Together, this will address 3 critical needs in the analysis of somatic mutations in normal tissues:
comprehensive mosaic mutation discovery, phenotyping the cell harboring mutations and directly
assessing functional consequences of mutations, and accurate and high-throughput detection of
SVs.
For this Supplement project, we will grow up an already-existing fibroblast line from a live donor,
as well as five already existing clonally expanded iPSC lines derived from that fibroblast line. We
will distribute cells from these lines to the GCCs of the SMaHT consortium, to be deep-sequenced
for the purpose of benchmarking on a resource for which already pre-validated somatic variants
at known tissue allele frequencies exist.

Public health relevance
Narrative Numerous recent studies have consistently shown that likely no two cells in the human body have the exact same genomes, a phenomenon called somatic mosaicism. Mosaicism can be studied using various approaches. For this Supplement, we propose to generate cell cultures that will be used across the consortium to benchmark approaches for comprehensive, accurate, and high- throughput analyses of somatic variation.